Assessment of hyperthermia-based multimodal approach for hepatic colorectal metastases

ABSTRACT
Worldwide, colorectal cancer is responsible for approximately 0.4 million deaths annually, which represent
approximately 10% of all cancer deaths. The main cause of death in colorectal cancer patients is hepatic
metastasis. Although regional treatment options, including hyperthermic isolated hepatic perfusion (IHP) and
percutaneous IHP, offer the benefits of both aggressive local treatment and limited systemic toxicity, the
management of unresectable hepatic colorectal metastases remains a major unsolved issue and more
effective novel regimens are needed. During the grant period, we propose developing a novel treatment
strategy for hepatic colorectal metastases. Considering our previous studies, the combined treatment of
hyperthermia, TRAIL (tumor necrosis factor-related apoptosis-inducing ligand), and ferroptotic agent
synergistically induces cytotoxicity and effectively enhances the tumoricidal efficacy of subcutaneous
xenografts. In this grant application, we hypothesize that a combinatorial treatment of mild
hyperthermia, the biologic agent TRAIL, and the ferroptotic agent artesunate (ART) is effective in
treating unresectable hepatic colorectal metastases (HCM). The specific aims of this project are to (1)
elucidate the mechanism of synergistic anti-tumor efficacy caused by hyperthermia in combination with TRAIL
and ART treatment (HTA: hyperthermia + TRAIL + ART) in tumoroid models, and (2) investigate the preclinical
efficacy of this HTA treatment in humanized rat isolated hepatic perfusion (IHP) models. The proposed studies
for the first aim will establish tumoroid models with tumor tissues from patients with HCM and employ
biochemical and molecular techniques to investigate the cell death mechanism induced by synergistic effects
of the HTA treatment. For the second aim, we will develop humanized rat IHP models with tumor tissues from
patients with HCM and then evaluate the therapeutic advantage of the HTA treatment. We believe that the
successful outcome of this study will support the application of this multimodal approach to HCM.

Public health relevance
NARRATIVE Colorectal cancer is one of the most common cancers in both men and women in the United States and accounts for approximately 140,000 new cases annually. Hepatic metastasis, the dominant feature of life- limiting disease, occurs in approximately 20–50% of patients with colorectal cancer. In this study, we propose developing a novel strategy (hyperthermia + ferroptotic agent + TRAIL) to treat colorectal liver metastases.